Development of a Novel Animal Model for Spinal Cord Injury with Sepsis

Summary Abstract
Sepsis is a predominant life-threatening secondary complication following traumatic spinal cord injury (SCI).
Several predisposing factors such as polytrauma, prolonged/repeated hospital stay, pressure ulcer, and
indwelling catheters make SCI patients more susceptible to microbial infections that can lead to sepsis. Sepsis
is a leading cause of death after spinal trauma and is associated with poor functional outcomes among survivors.
Depending on the time of onset, there are two sepsis types. Sepsis diagnosed within 48hr of initial injury is
termed “primary” sepsis, and when its onset occurs after 48hr, it is known as “secondary” sepsis. Though sepsis
with SCI is a serious condition leading to diminished life expectancy and quality of life, this combined medical
issue has not been well studied. This is mainly due to lack of an appropriate animal model. Accordingly, the goal
of proposed study is to develop and validate a novel clinically relevant rodent model that closely mimics the long-
term dysfunction of survivors of sepsis after SCI. This model will be validated with six parameters: 1) survival
rate, 2) infection severity, 3) inflammatory cytokines, 4) locomotor score, 5) muscle force and 6) histopathology.
Our team has developed a clinically relevant rodent sepsis model consisting of polymicrobial abdominal sepsis
by cecal slurry (CS) injection followed by a delayed but repeated ICU-like resuscitation procedure with fluids and
antibiotics; this refined model allows us to investigate long-term physical dysfunction among sepsis survivors.
Our main approach is to combine this long-term sepsis survivor model with rat spinal contusion model to mimic
either “primary” (Aim 1) or “secondary” (Aim 2) sepsis after SCI. Our central hypothesis is that the cumulative
effects of sepsis plus SCI will impair spontaneous motor recovery, limit spinal cord tissue sparing, exacerbate
skeletal muscle weakness, and increase mortality. Two specific Aims are designed to test this hypothesis. In
Aim 1, we will induce sepsis immediately after SCI to mimic “primary” sepsis by CS injection followed by ICU-
like resuscitation initiated at 8 hrs. To mimic “secondary” sepsis, in Aim 2, we will induce sepsis at 6 weeks after
SCI by CS injection and resuscitation initiated at 8hrs after sepsis induction. SCI animals in Aim 1 will undergo
weekly locomotor testing for 6 weeks and in Aim 2, for a total of 12 weeks (6 weeks before sepsis induction and
6 weeks after) to assess spontaneous recovery. After final locomotor assessments, survivors will be subjected
to ex vivo muscle force testing, histological examination, and mitochondrial function analyses to assess muscle
weakness. Spinal cord tissue will be used for quantitative histology of spared gray and white matter as well as
lesion volume that will be correlated with locomotor recovery. Successful development of this model will allow
us to investigate detailed molecular/physiological mechanisms of sepsis following SCI, with a long-term goal of
developing therapeutic strategies to improve quality of life in the afflicted population. Success of this project is
assured by our strong multi-disciplinary team including Drs. Patel (MPI, SCI researcher), Saito (MPI, sepsis
researcher), Butterfield (Co-I, muscle researcher) and Stromberg (Co-I, biostatistician).

Public health relevance
NARRATIVE Sepsis is a predominant secondary complication that affects quality of life and reduces life expectancy in spinal cord injury (SCI) populations. Although sepsis after SCI is an existing clinical condition, this medical issue unfortunately is understudied due to lack of good animal models. Accordingly, the current innovative proposal is designed to develop, for the first time, a novel rat model of sepsis survivors following SCI to study compromised functional recovery as well as damage to various tissue/organ system(s) due to the compounding effects of SCI- sepsis.